Determining lineage decisions and gene regulatory networks governing the generation of key progenitor cell types during early human brain development

Abstract
The long term goal of this proposal is to quantitatively understand how gene regulatory networks (GRNs)
generate the diversity of cell types during the development of the human brain. The focus of this proposal is to
determine how key progenitor cell types that are uniquely enriched in humans are generated. Such an
understanding is essential for uncovering the mechanisms of human developmental diseases. There are three
challenges to achieving this goal: 1. Ethical issues in working with developing human tissue, 2. Computational
and experimental techniques to determine the sequence of progenitor cell states and state transitions that give
rise to the diversity of cell types, 3. the difficultly in building quantitative models of the gene regulatory networks
in the absence of data to determine the thousands of biochemical constants. The approach of the proposal is to
build the necessary computational, mathematical and experimental framework to overcome these challenges.
To recapitulate early human brain development, the proposal will employ an in vitro human embryonic stem cell
differentiation system. To obtain snapshots of the underlying gene regulatory network, high throughput single
cell sequencing will be employed to obtain transcriptional profiles of thousands of single cells during the course
of development. The challenge of inferring the sequence of cell states and cell state transitions will be overcome
through a novel statistical method to obtain a joint probability distribution of the cell states, sequence of transitions
and a key set of genes whose dynamics reflect these states and transitions. The inferences will be tested by
mapping to in vivo data and using viral lineage tracing. The origins of forebrain and outer radial glial cells (oRG)
progenitors uniquely enriched in the developing human forebrain will thus be determined.
The challenge of building predictive models will be overcome by using methods from theoretical physics and
ensemble modeling from statistics to build models that make probabilistic predictions. By using the available
data as constraints on the model, the framework will extract joint probability distributions of all the parameters of
the model. These distribution functions will then be used to produce probabilistic predictions about the responses
of the underlying GRNs to perturbations. High probability predictions will be tested experimentally by perturbing
gene expression and signaling during early brain development and the model will be iteratively improved. The
success of this proposal will result in the first quantitative model of the gene regulatory network controlling the
generation of forebrain and the oRG progenitor cells. If achieved, this work therefore would represent a major
insight into the molecular and cellular events that give rise to the disproportionately gyrated human brain.

Public health relevance
Narrative The project seeks to gain a quantitative understanding of the molecular networks within cells that control the generation of key progenitor cell types that arise during human brain development. To do so, it will develop modeling and computational tools as well as test these tools on human embryonic stem cell lines. In the longer term, a quantitative understanding of the circuits within cells that control development will allow us to uncover mechanisms underlying developmental disease.